Linked Whole Slide Imaging (WSI) for Cancer Surveillance

The purpose of this call order is to provide support in the area of quality control and improvement of cancer data, specifically in obtaining and processing digital WSIs and associated metadata for cancers cases ascertained through the SEER cancer registry system.